The Role of Platelets in Establishing the Lung Pre-Metastatic Niche in Breast Cancer

PROJECT SUMMARY
Tumor metastasis remains responsible for >65% of cancer-associated mortality and nearly all
breast cancer deaths. Given the difficulties in treating metastatic disease, preventive approaches
that block the successful dissemination of tumor cells to distant organs like the lung offer an
attractive and under-researched therapeutic strategy for breast cancer patients at risk of
metastatic disease. Primary tumors increase metastatic efficiency by reprogramming the
microenvironment of distant organs before the arrival of circulating tumor cells. These tumor-
permissive sites are commonly referred to as the “pre-metastatic niche” (PMN) and undergo a
series of cellular and structural adaptations that support arriving tumor cells, including the
recruitment of inflammation-promoting and immunosuppressive cells, neoangiogenesis, and
stromal remodeling. Despite their archetypal roles in hemostasis, blood platelets are integral to
inflammatory lung diseases and regulate many of the hallmarks adopted by the PMN. I, therefore,
hypothesize that platelets promote the lung PMN. My preliminary data support this statement,
demonstrating that platelets are sequestered in pre-metastatic lungs and that lowering platelet
counts reduces immune cell recruitment to the lung PMN. To expand on these initial findings, this
research will determine the contributions of platelets to the lung PMN (Aim 1), elucidate
mechanisms by which platelets impact the lung pre-metastatic environment (Aim 2), and test if
therapeutically targeting pre-metastatic platelet number or function impairs metastasis (Aim 3).
The technical skills and scientific expertise I will obtain throughout the K99 award period will prove
instrumental in my transition into an independent researcher, with the long-term goal to develop
novel preventative and adjuvant therapeutic strategies for patients at risk of metastatic breast
cancer. To reach these long-term goals, I have outlined a detailed career development plan, which
will provide me with the technical and leadership skills to establish a successful research
laboratory. The K99 phase of research will be conducted under the excellent (co)mentorship of
Drs. Elisabeth Battinelli and Sandra McAllister at the Hematology Division of Brigham and
Women’s Hospital. My Research Advisory Committee and collaborators are leading experts in
the breast cancer PMN (Dr. Moses), platelet production (Dr. Italiano), and targeting platelets for
breast cancer therapy (Dr. Chen). This K99/R00 award will provide me unparalleled support for
my successful transition to an independent investigator studying platelet and cancer biology.

Public health relevance
PROJECT NARRATIVE Because metastasis remains the major cause of mortality for breast cancer patients, understanding the mechanisms underpinning its progression is crucial for developing drugs that target this deadly process. My research proposal will expand our fundamental knowledge of tumor metastasis by investigating how blood platelets promote the formation of tumor cell-permissive sites, commonly referred to as the “pre-metastatic niche”. The overarching goal is to develop platelet-targeting adjuvant and preventative therapeutic strategies that improve the outcomes of patients at risk of metastatic breast cancer.